POSTDOCTORAL TRAINING PROGRAM IN SAS PREVENTION

This proposal is for the competitive continuation of the currently- funded Postdoctoral Training Program in Substance Use and AIDS (including Sexually Transmitted Diseases) Prevention Research [SAS Prevention Research] at the University of Illinois at Chicago (UIC), and to add a predoctoral component to it. The continuation is called the Prevention Research Training (PRT) Program for training in research on the prevention of Substance Abuse (SU), AIDS/STDs, and Violence (SAV). The PRT Program is located in the Health Research and Policy Centers (HRPC, formerly the Prevention Research Center) directed by the PI, the Community Outreach Intervention Program (COIP) directed by Dr. Wayne Wiebel, co-director of the training program, and several academic units (Community Health Sciences (CHS) and Epidemiology/Biostatistics (Epi/Bio) in the School of Public Health, Psychology, Criminal Justice, the Midwest Training and Education Center (MATEC) in the School of Social Work, Nursing, Education. The purpose of the PRT Program ius to provide integrated and comprehensive training to predoctoral and postdoctoral fellows in the prevention of substance use/abuse (SU), AIDS and sexually transmitted diseases (AIDS/STDs) and violence. Emphasis in the program is on the knowledge and skills necessary for rigorous and high-quality prevention research. Our underlying educational assumption is that fellows must be well grounded in three broad areas: 1) research methodology, statistics and ethics, 2) epidemiology of SAV, and 3) sciences of behavioral and social change. In addition, they require some understanding of public health, including the impact of public health policy and management on the design, implementation and evaluation of prevention programs, and the role of health policy and management on preventing SAV. The duration of both the predoctoral and postdoctoral training program is three years, and both provide a structured research training experience that integrates course work and core prevention research experience, seminars and intervention rotations in a multi-disciplinary context with multi- disciplinary faculty. UIC faculty have a large number of research projects on the etiology and prevention of SAV, many with disadvantaged and minority youth and their family, schools and communities.